Phytoremediation of Metal-Contaminated Mine Sites in Drylands

ABSTRACT (Project 4: Maier, Babst-Kostecka, Babst, van Leeuwen)
The metal-mining industry generated 44% of total toxic waste in the U.S. in 2021, primarily in western dryland
ecosystems. This project will develop transformative science to understand and mitigate soil metal contamination
and particulate emission from this waste addressing two NIEHS Superfund Research Program Mandates.
Mandate 4: reducing the amount and toxicity of hazardous substances is addressed through our focus on
phytoremediation of metal-contaminated dryland ecosystems. Successful phytoremediation will result in a
vegetation cover that can reduce both wind and water erosion of mine wastes with a concomitant reduction in
human and ecosystem exposure to toxic metals. Mandate 3: methods and technologies to detect hazardous
substances in the environment is encompassed by our goal to develop technology combining Light Detection
and Ranging (LiDAR) and hyperspectral imaging technology to provide enhanced capabilities in detecting plant
stress, particularly nutrient deficiency and heavy metal contamination, as well as identifying vegetation
productivity and structural changes. If successful, this technology will offer a low-cost approach to rapidly
evaluate and map spatial variability across large land areas for planning and prioritizing remediation efforts. The
current paradigm for phytoremediation of dryland mine wastes is the use of phytostabilization to immobilize
metals in the plant root zone. This approach is currently accepted by the mining industry and regulators as the
preferred remediation option, but it implies that a sizeable amount of metals is left unused in the ground. In this
continuation proposal we offer an alternative transformative paradigm. We propose using metal-
hyperaccumulator plants to achieve both a sustainable vegetative cover for metal-contaminated sites and the
opportunity for metal recovery. This new paradigm would reduce the need to mine new sources by returning
metals that were mined and “disposed” into soils back into the supply chain. Removing metals from a site using
this process (phytoextraction) can take decades. We view this as an advantage because phytoremediation has
the potential to create jobs and revenue streams for communities affected by mining. After each growing season,
metals would be recovered by harvesting and processing the plant biomass. Deliverables from this project will
include guidelines and tools for targeted phytoremediation solutions, including an improved understanding of
and capacity to spatially quantify metal contamination across Superfund sites to help prioritize areas for
remediation. We will work with our Research Translation and Community Engagement Core teams to identify
mines and neighboring communities that have an interest in testing and applying these new technologies on
their sites

Public health relevance
PROJECT NARRATIVE (Project 4: Maier, Babst-Kostecka, Babst, van Leeuwen) Mining pollution has overwhelmed remediation efforts in many rural and urban dryland areas in the US Southwest and beyond. This calls for new eco-friendly and low-cost solutions to prioritize and remediate sites to mitigate the impact of this hazardous waste on human health in communities neighboring mining waste. The proposed research will advance site characterization capabilities and optimize remediation technology to generate lasting vegetation covers that can stabilize mining wastes while recovering metals for reuse and preventing transport of associated contaminants via wind or water into surrounding areas.